Mechanisms of Th17-DC immunotherapy for ovarian cancer

The clinical experience with anti-PD-1 immune checkpoint inhibition in ovarian cancer has been disappointing.
The poor outcomes may at least in part be due to the highly immunosuppressive tumor microenvironment
(TME) and the low tumor mutational burden in ovarian cancer, suggesting relatively limited immunogenicity
and anti-tumor T cell responses. These barriers may be overcome by clinically relevant combinatorial
treatments that (i) stimulate anti-tumor T cell immunity and (ii) alleviate immune suppression in the tumor
microenvironment. Favorable clinical results from a recent trial of Th17-inducing dendritic cell (Th17-DC)
vaccination in patients with stage III/IV ovarian cancer provided a strong foundation for Th17-DC vaccine-
based combinatorial approaches to immunotherapy in ovarian cancer. Indeed, follow-up studies in a mouse
model of ovarian cancer showed that Th17-DC vaccination could dramatically improve responses to anti-PD-
1 immune checkpoint inhibition.
Several lines of evidence have pointed to a key role for B cell responses in the anti-tumor activity of Th17-DC
vaccination. In this proposal, we will test the hypothesis that the efficacy of anti-PD-1/Th17-DC vaccination is
dependent on host B cell responses in the following Specific Aims:
Aim 1) Determine whether the efficacy of anti-PD-1/Th17-DC vaccination combinatorial immunotherapy is
dependent on B cells
We will evaluate the role of B cells in anti-PD-1/Th17-DC vaccine-induced antitumor immunity by in
vivo depletion of B cells in the ID8 p53-/- and the ID8 p53-/- BRCA2-/- mouse models of ovarian cancer.
Aim 2) Determine whether the efficacy of anti-PD-1/Th17-DC vaccination combinatorial immunotherapy is
associated with the formation of tertiary lymphoid structures (TLS)
We will correlate the prevalence and morphology of TLS in ID8 p53-/- and ID8 p53-/- BRCA2-/- ovarian
tumors with therapeutic responses to anti-PD-1/Th17-DC vaccination. We will also identify TLS gene
signatures associated with therapeutic responses.
The potential synergy between Th17-DC vaccination and anti-PD-1 may have considerable impact for the
future use of immune checkpoint inhibitors for treatment of ovarian cancer. The novel concept that the efficacy
of Th17-DC vaccination (itself an innovation), either as monotherapy or combined with anti-PD-1 immune
checkpoint inhibition, is ultimately dependent on B cell responses also has high impact for the field.

Public health relevance
Narrative The clinical experience with anti-PD-1 immune checkpoint inhibition in ovarian cancer has been disappointing. We have shown that a novel Th17-inducing dendritic cell vaccine markedly enhances responses to anti-PD- 1 treatment in a mouse model of ovarian cancer, thus paving the way for a phase II clinical trial for Th17-DC vaccination plus pembrolizumab in patients with advanced stage ovarian cancer. This proposal will test the paradigm-shifting hypothesis that the efficacy of anti-PD-1/Th17-DC vaccination is dependent on host B cell and antibody responses.